Proteasome dysfunction as a driver of age-associated risk for Alzheimer's disease onset and progression

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD) affects 5.5 million Americans, producing cognitive deficits and mortality. There are
very limited treatment options for AD, making development of interventions to slow or reverse AD symptoms a
critical area of research. Proteasome function declines in the brain with age, an impairment that is even more
pronounced in patients with AD; this is also seen in animal models of AD. Using in vivo invertebrate and in vitro
vertebrate models of AD, we have found that genetic and pharmacologic augmentation of the proteasome can
delay AD-like cognitive and neurodegenerative symptoms, while reducing proteasome function accelerates AD
progression. Building on these findings, we now propose to investigate (a) the mechanism of action and (b)
efficacy of proteasome manipulation as a possible intervention for AD. This proposal has three goals: 1) To
determine if drug and genetic manipulation of proteasome function reduce AD-like symptoms in mice
that model the disease. This is a natural progression from our prior studies of these interventions in flies and
cell culture and is supported by our strong preliminary data in mice. 2) To elucidate how proteasome
dysfunction is linked to AD progression. We present, and test, two hypotheses to explain this interplay. The
first hypothesis is that the proteasome has a key role in prevention of AD progression through degradation of the
β-amyloid (Aβ) machinery, specifically, amyloid precursor protein (APP), β-secretase (BACE1), and γ-secretase
activating protein (GSAP), all of which are targets of proteasome degradation. If so, it would indicate that age-
related declines in proteasome function result in accumulation of these proteins, which drives AD pathogenesis.
The second hypothesis is that proteasome dysfunction, triggered by Aβ inhibition, drives downstream
neurodegeneration rather than altering Aβ accumulation. Proteasome dysfunction on its own causes
neurodegeneration and synaptic loss. If our findings are consistent with this hypothesis, it would indicate that
proteasome dysfunction caused by Aβ inhibition is an intermediator for AD-induced cognitive deficits and
neurodegeneration. 3) To establish the role and timeline of proteasome dysfunction in AD patients and
the translational potential of our proteasome-targeting interventions. Prior studies report impaired
proteasome function in AD patients beyond that seen in age-matched controls. However, it is unclear if this
impairment is a driver of pathogenesis or a product of disease progression. This investigation will use human
tissue to establish where proteasome dysfunction occurs in the AD cascade and whether it co-varies with disease
state, severity, symptom presentation, and biomarkers of the disease. This will establish the translational
potential of our proteasome-targeting pharmacologic agents. If our investigations are successful, we will enhance
mechanistic understanding of the role of the proteasome system in AD and lay the groundwork for preclinical
trials of a new class of AD-targeting drugs.

Public health relevance
PROJECT NARRATIVE Increasing the function of the proteasome (protein complexes involved in protein turnover) can reduce cognitive deficits associated with aging as well as in various models of Alzheimer’s disease. We now plan to test whether genetic and pharmacologic manipulation of this system can rescue cognitive deficits in mouse models of Alzheimer’s disease, and to examine how proteasome manipulation alters Alzheimer’s disease progression. The ultimate goal of this work is to develop new drugs and interventions aimed at slowing or preventing Alzheimer’s disease progression.